Emerging Strategies for Therapy of Metastatic Brain Cancer

PROJECT SUMMARY
Brain cancer remains a devastating disease and in particular, brain metastases (BM) from breast cancer
represent the leading cause of fatality for women. The major hindrance to significant clinical benefit for BM is the
poor permeability of monoclonal antibodies (i.e. trastuzumab) across the blood brain barrier (BBB), resulting in
surgical resection and radiation therapies as the first line therapeutic options. With our team of experienced and
highly accomplished scientists with strong track record in basic, translational, and clinical research, we propose
to advance the science of metastases to the brain by focusing on 1) understanding of fundamental biology of
HER2+ breast cancer metastases to the brain via patient tissue-based genetic dissection of risk factors 2) the
advancement in real-time of visualization of cancer cells and neural stem cells (NSCs) targeting HER2+ BM and
3) the application of targeted NSC delivery of trastuzumab analogs to suppress the growth of HER2+ BM. The
novel paradigm established by this application will advance our understanding of how cancer cells invade and
spread thru the brain and potentially help herald an era of genetically engineered stem cells as targeted delivery
conduit for anti-HER2 therapy against HER2+ BM.

Public health relevance
PROJECT NARRATIVE Brain cancer is a leading cause of death and brain metastases represent a highly unmet clinical need. In particular, brain metastases from breast cancer are associated with dismal prognosis. This proposal seeks to elucidate the mechanisms by which breast cancer spreads to the brain, utilizing our in vivo models to evaluate brain tumor tropic genes, novel imaging methods of cellular tracking in the CNS, and ultimately development of a novel stem cell-based therapy for HER2+ brain metastases.